Administrative Supplement to Purchase Fluorescence Microscope

Project Summary The parent grant proposal grant aims to dissect how proteins fold in eukaryotic cells. Access to cutting-edge microscopy has become critical to study the problem of protein folding in the cell. The ability to pinpoint the location of chaperones and substrates with respect to each other and to cellular organelles in the cell is increasingly dependent on resolving imaging targets in greater detail ? necessitating super-resolution microscopy. The experiments in this grant (as well as all experiments in my other RO1 grant GM074074) will benefit enormously from acquiring a microscope capable of carrying out super-resolution microscopy approaches. We request an administrative supplement to purchase a benchtop super-resolution fluorescence microscope.

Public health relevance
Project Narrative We hereby request an administrative supplement for our R37 grant GM056433 “Protein Folding in the Eukaryotic Cytosol” to purchase a benchtop super-resolution fluorescence microscope with capabilities to carry out TIRF, dSTORM and SIM experiments.